Targeting the EGFR-PI3K/mTOR Signaling Circuitry: A Network-Based Approach for Oral Cancer Precision Therapy

Project Summary
There are currently no effective targeted therapies for oral squamous cell carcinoma (OSCC), which includes
cancers of the oral cavity and oropharynx, a disease that results in ~300,000 deaths each year worldwide. There
is an urgent need to develop new therapeutic options to prevent and treat OSCC. A striking finding from the
recent deep sequencing of the OSCC genomic landscape was the remarkable multiplicity and diversity of genetic
alterations in this malignancy. The emerging picture, however, is that most fall within only a few major driver
biological processes, including mitogenic signaling with particular emphasis on aberrant activation of the
PI3K/mTOR pathway. Among them, PIK3CA, encoding the PI3Kα catalytic subunit, is the most commonly
mutated oncogene in OSCC (~20%), with a significant enrichment in (HPV)-associated tumors (25%). Our team
has focused on the study of oncogenic signaling circuitries driving OSCC initiation and progression, aimed at
identifying novel druggable targets for OSCC prevention and treatment. These efforts led to our early discovery
that the persistent activation of the PI3K/mTOR signaling circuitry is the most frequent dysregulated signaling
mechanism in OSCC, and that PI3K/mTOR inhibition exerts potent antitumor activity in a large series of
genetically-defined and chemically-induced OSCC models. These findings provided the rationale for launching
a multi-institutional Phase II clinical trial (NCT01195922), targeting mTOR in OSCC, which was recently
completed and achieved encouraging results. However, 80% of the OSCC lesions lack driver PIK3CA mutations,
and to date, we cannot predict the sensitivity or resistance to EGFRi and PI3K/mTORi in the context of an
individual tumor, which may help explain prior treatment failures with PI3K/mTORi in unselected advanced
OSCC patients. We have also shown that PIK3CA mutations may underlie cetuximab resistance, which can be
overcome by mTOR inhibition. We will investigate the therapeutic potential of co-targeting the EGFR-
PI3K/mTOR signaling circuitry based on the genetic stratification of PI3K/mTOR network subtypes, alone or
combined with immune oncology agents with the goal to develop novel precision therapeutic approaches for
OSCC. To this end, we will exploit the emerging information about the OSCC genomic landscape to a) identify
alterations driving PI3K/mTOR activation in the OSCC lesions that lack PIK3CA mutation and explore their
contribution to cetuximab resistance and sensitivity, b) identify novel systems vulnerabilities associated with
cetuximab and PI3K/mTORi sensitization and c) establish the impact of targeting and co-targeting the EGFR-
PI3K/mTOR signaling network on the tumor and immune microenvironment, and response to novel immune
oncology agents. Ultimately, our efforts will a) overcome EGFR-PI3K/mTORi resistance mechanisms via
network-based co-targeting strategies, b) increase the efficacy of novel immune checkpoint inhibitors by
targeting oncogenic circuities, and c) inform the molecular stratification of OSCC for patient selection in future
precision and immune oncology trials.

Public health relevance
Narrative There is an urgent need to develop new therapeutic options to prevent and treat oral squamous cell carcinomas (OSCC). Our overall objective is to exploit the emerging information of the OSCC genomic mutational landscape to identify alterations driving aberrant activation of the tumor promoting pathway PI3K/mTOR, the best targeted therapeutic options, and help prevent or overcome drug resistance. Ultimately, our efforts will help uncover new genetic determinants of the efficacy of newly developed PI3K/mTOR inhibitors under current clinical evaluation, overcome resistance mechanisms via rationale combination therapies, and inform the molecular stratification of OSCC for patient selection in future precision and immune oncology trials.